ANTIGEN INDUCED MEDIATOR RELEASE IN HUMAN LUNG

The role of eicosanoids and other inflammatory mediators in causing asthma and nonspecific airway reactivity is being examined using bronchoscopy, alveolar lavage, allergen instillation and drug treatment (steroids, cyclooxygenase and 5-lipoxygenase inhibitors).